Genetics and Biology of Pancreatic Ductal Adenocarcinoma

Overall -­ Abstract/Summary.
This multi-­disciplinary team focuses on the role of oncogenic Kras (Kras*) in pancreatic ductal adenocarcinoma
(PDAC) with an emphasis on understanding the interplay between Kras* cancer cells and the tumor
microenvironment (TME). Our objectives are to elucidate cancer cell intrinsic and TME mechanisms responsible
for resistance to Kras* extinction as well as to define co-­dependent circuits controlling metabolism and immunity.
Our P01 program comprises three highly interdependent projects and three essential scientific cores. Project 1
(DePinho with Allison) will continue to focus on elucidating the functional basis for escape from Kras*
dependence, which includes intrinsic mechanisms as well as paracrine signaling involving myeloid populations.
These cancer cell-­TME interactions also uncovered the importance of myeloid cells in suppressing tumor
immunity, providing the basis for rational development of novel immunotherapy regimens with truly
unprecedented anti-­tumor responses. Project 2 (Bardeesy with Kimmelman and Cantley) has studied the role
of Kras* in driving anabolic growth of cancer cells and the importance of lysosomal degradative pathways in both
tumor cell metabolic homeostasis and immune evasion, leading to new clinical trials testing autophagy inhibition
in PDAC. Project 2 now seeks to explore how specific oncogenes/tumor suppressors co-­mutated with Kras*
influence metabolic dependencies as well as the immune composition of the TME. Project 3 (Kalluri with Ying)
brings together these two concepts of immunity and metabolism in the context of the unique stromal biology of
PDAC. Specifically, tumor immunity and metabolism are explored from the viewpoint of a novel Kras*-­induced
paracrine program involving a unique oncogenic type I collagen variant and a3b1 integrin signaling in the TME.
Project 3 also utilizes its exosome technology platform in targeting Kras* combined with refined immune or
metabolism regimens emerging from the other projects. The close interaction of each Projects with various
clinical platforms, including the Immunotherapy Platform and the Parker Institute for Cancer Immunotherapy at
MD Anderson directed by Dr. James Allison (Investigator of Project 1), will constantly inform the work from this
P01 team and, vice versa, guide the clinical trials in real time. Highly innovative Cores for Pathology (Maitra),
Modeling & Experimental Therapeutics (Horner), Computation (Futreal), along with the Administrative Core will
enable the full potential of these Projects.

Public health relevance
Overall Program - Narrative (Genetics and Biology of Pancreatic Ductal Adenocarcinoma) Pancreatic cancer will be the second leading cause of cancer death in 15 years and remains incurable. This program project aims to identify therapeutic intervention points through various state- of- the- art technologies and animal modeling. The goal remains to gain sufficient understanding of PDAC genetics and biology to inform the implementation of effective therapeutic combinations.